PROTEIN METABOLISM IN MOTHERS WITH SMALL FOR GESTATIONAL AGE FETUS

The goal of this project is to assess protein metabolism and its response to feeding in late pregnancy in mothers of small-for-gestational-age fetus. The authors will perform euglycemic-hyperglycemic clamps and measure protein turnover with 13-C-leucein and 2-H-5 phenylalanine. During the last 3 hr of the clamp, they will infuse an amino acid mixture. Body composition will be determined by BIA and with 2-H2O.